Real-time Conversion and Display of Visual Diagrams in Accessible Forms for BVIs

PROJECT SUMMARY
Visual diagrams are playing an increasingly dominant role in providing information in education, employment
and daily living. Unfortunately, individuals who are blind or visually impaired (BVIs) experience enormous
obstacles in independently accessing this information, impacting their success in all aspects of their lives.
The proposed project intends to addresses this critical need through the development of a low-cost system for
the real-time automatic conversion of visual diagrams into accessible dual vibrotactile and enhanced visual
forms rendered on aligned, refreshable tactile and visual displays, allowing BVIs to use touch, their residual
vision or a combination of both to access graphical information. To ease the significant time and cognitive load
required by users to interpret accessible diagrams, automated haptic guidance will be available to help BVIs
explore a diagram through shared control with the user. Basic alt-text descriptions will also be available, both in
Braille and in spoken form, to also support the effective exploration of the diagram. A participatory design
approach will be used for the system’s development, involving BVIs and other stakeholders in: focus groups,
low technology prototyping and user testing both in the laboratory and in the field.
The display system will consist of a low-cost refreshable haptic display, previously developed in one of the
PI’s laboratories, combining multi-fingered tactile feedback with shared control of movement between the user
and haptic guidance fixtures (with user adjustable weightings) to which an enhanced vision display will be
added. Machine learning will be used to convert visual diagrams to an accessible form useful for both lower
level and higher-level thinking. To obtain a more effective model for conversion, the key component to our
approach is to take advantage of the underlying structure of known diagram types, with separate models for
graphs and charts (simple and highly structured), illustrations and photos (complex and least structured), and
maps and engineering diagrams (focused on the connectivity of elements and using a symbol set). The R61
Phase of the project will focus on providing a beta version of the complete system for simple, high impact
graphics (graphs and charts) through multiple design iterations with BVI user testing in the laboratory. The R33
Phase of the project will deploy the beta version in the field with BVI users to further assess and improve the
design for real world use. This phase will also work on the development of conversion methods for illustrations
and photos, and indoor/outdoor maps and engineer diagrams, again through multiple design iterations with BVI
user testing the laboratory. Dissemination will also occur during this stage.

Public health relevance
Modified Public Health Relevance Section The project intends to build and deliver a low-cost system for the real-time automatic conversion of visual diagrams into accessible dual vibrotactile and enhanced visual forms rendered on aligned, refreshable tactile and visual displays. It will also provide haptic assistive support, to the degree desired by the user, for exploring the accessible diagram. This will provide individuals who are blind or visually impaired independent on-demand access to the information in visual graphics, which are ubiquitously used in daily living.